Targeting Dentate Gyrus to Disrupt Fentanyl-Linked Context Memories

PROJECT SUMMARY
Addiction is a chronic, relapsing disorder, characterized by persistent drug-taking behavior despite negative
consequences. New therapies are needed that prevent relapse.One trigger for relapse is the context where
drug use previously occurred. When a rewarding drug is taken in a particular context, a “reward-context
memory” can be formed. Reward-context memories are powerful; placing a human or rodent back into a
reward-linked context can provoke drug craving. Disruption of reward-context memories is thought to prevent
addiction. However, to disrupt reward-context memories, we have to first understand their neural basis.The
neural basis of reward-context memories can be informed by literature on fear-context memories. Fear-context
memories are reliant on the hippocampal dentate gyrus (DG) and a discrete population of DG context memory
cells—termed an “engram”. Inhibition of DG fear-context memory engrams disrupts fear memory recall. It is
unknown whether the DG is a site of reward-context engrams or if inhibition of the DG disrupts reward-context
memory recall. Stimulation of the DG prior to context-fear memory encoding enhances fear-context memory. It
is unknown if stimulation of the DG prior to reward-context memory enhances reward-context memory recall.
My objective is to assess if DG reward-context memories can be manipulated, with the long-term goal of
diminishing the salience of context cues and preventing relapse. The Aims of this proposal are to 1) test if DG
neurons active during reward-context memory encoding can be inhibited during re-exposure to the
reward-context, reducing or inhibiting drug-linked context memory recall and 2) determine if stimulation of DG
neurons during reward-context memory encoding improves drug-linked context memory recall. When
completed in two years, these experiments will determine whether or not the DG can serve a novel therapeutic
target for diminishing the salience of drug-context memories. Further, regardless of experimental outcome, we
will be able to elucidate novel properties of reward linked memories. Starting my postdoc during Covid-19 and
moving into a new field (from context fear memory to addiction), it took time for me to establish a baseline
knowledge and generate pilot data in order to develop these aims. Through this fellowship, I will accomplish
defined Training Goals: learn hippocampal circuit manipulation, develop expertise in the field of substance
abuse in the context of disordered learning/memory, use machine learning for the characterization for reward
behaviors, and gain further professional development skills including project and personnel management. I
have a supportive and ideal mentoring team (Drs. Amelia Eisch and Julie Blendy) to guide my training of both
conceptual and technical skills. At the Children’s Hospital of Philadelphia and University of Pennsylvania
Perelman School of Medicine, I have exceptional resources and a stimulating environment in which to
accomplish these goals.The completion of these Aims, and the training provided within, will provide the
foundation for my path to becoming an independent investigator at an academic institution.

Public health relevance
PROJECT NARRATIVE Addiction is a chronic, relapsing disorder, and treatments for relapse are lacking. A key relapse trigger is the environment — or context — in which drugs were previously taken. This proposal investigates whether memories of a drug-linked context can be manipulated to disrupt the association between a context and an addictive drug, and thus preventing relapse.